Aberrant proteomes in tauopathy: revealing functional consequences via multimodal proteomics

SUMMARY
Tauopathies including Alzheimer’s disease (AD) and frontotemporal dementia (FTD) are a group of devastating
neurodegenerative diseases that currently affect over 30 million people worldwide. Tau pathology correlates with
neuronal loss in AD and several mutations that increase tau aggregation cause familial forms of FTD, suggesting
tau aggregation plays an important role in the pathogenesis of neurodegeneration in these diseases. Indeed,
tau-lowering therapies are being evaluated in clinical trials for AD. Despite this central importance of tau in the
pathogenesis of AD and related tauopathies, the molecular and cellular mechanisms by which pathological tau
drives neurodegeneration are poorly understood. Thus, a systematic elucidation of these mechanisms would
transform our understanding of AD and related dementias, and also open up new avenues for therapeutic
approaches that could be beneficial in patients in which tau pathology has already been established and
downstream effects have already affected neuronal function. Here, we propose to combine our expertise in mass
spectrometry-based proteomics (Swaney) and functional genomics (Kampmann) to comprehensively map the
impact of tau pathology on the proteome, which we expect to be mediated in part through disruptions in mRNA
splicing, and measure the functional consequences of this pathology with cell type, subcellular, and molecular
resolution. This work leverages AD mouse models and human iPSC tauopathy models for discovery of protein
drivers of tauopathy, as well as validates such drivers in human post-mortem brains. Importantly, our approach
will measure multiple modalities of protein function to provide a holistic view of the diversity of functional
consequences incurred in neurons and brains with tau pathology. We anticipate these results will deepen our
understanding of molecular mechanisms of AD and ADRD and have the potential to pinpoint novel therapeutic
targets.

Public health relevance
NARRATIVE Pathological tau species are a predominant hallmark of Alzheimer’s disease, however we lack a systematic understanding of the functional consequences for the proteome and the role in disease progression. Here we propose to use a proteogenomic approach to comprehensively map the impact of tau pathology on disrupting the proteome with cell type, subcellular, and molecular resolution. These results will deepen our understanding of functional mechanisms driving Alzheimer’s disease and have the potential to pinpoint novel therapeutic targets.